A randomized, blinded, placebo-controlled field study to determine the efficacy and safety of TANOVEA-CA1 (rabacfosadine for injection) in dogs. Protocol Number VC-014.

RESEARCH & RELATED Other Project Information: Section 7 (Project Summary) Multicentric lymphoma is the most common cancer in dogs. The current standard of care consists of off-label generic chemotherapy drug regimens. There are no fully approved drugs for the treatment of lymphoma in dogs. Additionally, while multi- or single-agent treatment protocols frequently result in remission of disease, eventually all dogs will relapse. When relapse occurs, clinicians must utilize different cytotoxic agents, preferably agents with distinctive mechanism of action. TANOVEA®-CA1 (rabacfosadine for injection), is a double prodrug of the acyclic nucleotide phosphonate PMEG, preferentially targets lymphoma cells with reduced systemic toxicity and has shown potential in dogs that have never been treated as well as those no longer responding to single or multi-agent chemotherapy regimens. TANOVEA-CA1 is conditionally approved by the FDA (NADA 141-475) for the treatment of lymphoma in dogs. This study is being conducted to demonstrate substantial evidence of effectiveness in order to fulfill the pivotal data requirements for the new animal drug application effectiveness technical section in order to receive full approval. The study will be a randomized, multi-center, double-blinded, placebo-controlled study evaluating TANOVEA-CA1 at 1.0 mg/kg every three weeks for up to five treatments in dogs with lymphoma. The primary outcome variable will be progression free survival time as compared to the placebo control group. The secondary outcome variables are: overall response rate, best overall response rate and progression free percentage one month following completion of Cycle 5 (Month 4). Additionally, safety data, including the type and severity of adverse events, will be collected.

Public health relevance
RESEARCH & RELATED Other Project Information: Section 8 (Project Narrative) TANOVEA®-CA1 (rabacfosadine for injection) is a novel drug specifically designed to target and kill lymphoma cells, with the potential to achieve substantial overall response rates and remission times in dogs with lymphoma - the most common canine cancer. Under the requirements of the TANOVEA-CA1 conditional approval (NADA 141-475), a full demonstration of effectiveness must be established within 5 years, and this pivotal study will provide the data to demonstrate substantial evidence of effectiveness as well as additional safety information. These data will be used to obtain full NADA approval, and ensure that TANOVEA-CA1 will continue to remain available to veterinarians for the treatment of lymphoma in dogs.